Academic Year Health, Air Pollution, and Population Initiative in Education and Science Training (AY HAPPIEST)

PROJECT SUMMARY
The overall goal of the parent project is to train University of Utah (UOU) undergraduate students from
underrepresented racial/ethnic backgrounds in air pollution-related health research through a faculty-mentored
summer program called Health, Air Pollution and Population Initiative in Education and Science Training
(HAPPIEST). This administrative supplement will extend HAPPIEST research opportunities to the academic
year for selected participants. Since exposure to air pollution is magnified in racial/ethnic minority communities
in the United States, it is imperative to engage members of these communities—especially college students with
STEM interests—in addressing the complex problems caused by poor air quality and environmental inequity.
With this administrative supplement, we will achieve the following aims, which are within the original scope of
the peer-reviewed and approved project:
Aim 1. Extend the summer HAPPIEST mentoring “community of practice” model to the academic
year to enrich student training and deepen interdisciplinary collaboration on team-based
environmental health research.
Aim 2. Link the evaluation of academic year HAPPIEST to summer HAPPIEST to improve the quality
and effectiveness of all HAPPIEST programming, as well as inform future undergraduate research
training programs that aim to increase the participation of underrepresented groups in NIEHS-
related research.
In the parent award, the “community of practice” every summer includes four research teams, each with two
undergraduate students, one graduate student training coordinator, and at least one faculty mentor. The
administrative supplement will fund one academic year (AY) HAPPIEST research team, comprised to two
summer 2022 HAPPIEST undergraduates, a summer 2021 HAPPIEST graduate student training coordinator,
and three faculty mentors involved with HAPPIEST in summers 2021 and 2022. The interdisciplinary team will
work on a research project investigating transgenerational effects of industrial air pollution on intellectual
disability. Using an asset-oriented approach designed to build on student strengths, AY HAPPIEST activities will
prepare students for placement into competitive graduate programs in the environmental health sciences. The
project is of great

Public health relevance
PROJECT NARRATIVE The proposed administrative supplement seeks to build upon our successful summer R25 program—Health, Air Pollution and Population Initiative in Education and Science Training (HAPPIEST)—by extending air pollution- related health research opportunities to the academic year for students from underrepresented racial/ethnic backgrounds. Exposure to air pollution is magnified in racial/ethnic minority communities, and it is thus critical to engage affected populations in this area of research. The administrative supplement’s main contributions to public health are twofold: (1) to prepare students from underrepresented groups to enter STEM research, thereby diversifying the pool of talented scientists; (2) to advance knowledge in environmental health science thereby informing innovative solutions for air pollution-related health problems in the Salt Lake Valley and beyond.